Robot-based Information and Support to Enhance Alzheimer's Caregiver Health (RISE)

Project Summary/Abstract
The burden of caring for persons with Alzheimer's disease and related dementias (PwADRD) often falls on
unpaid caregivers, usually family members or friends. The mental, emotional, and physical stress associated
with such caregiving can lead to adverse health outcomes for the caregivers themselves. Recognizing this, our
project aims to develop and evaluate the Robot Interaction Scale of Engagement (RISE) system, a novel tool
designed to support these caregivers. By leveraging advanced artificial intelligence, the social robot, Pepper,
and the (Resources for Enhancing Alzheimer’s Caregivers Health) REACH Community and REACH VA
content, the RISE system aims to provide caregivers with essential information on effective care strategies,
self-care and coping, and stress management techniques. The goal is to enhance caregivers’ ability to provide
care and improve their well-being.
The specific objectives of the project are to: (1) tailor an AI-driven social robot to engage caregivers, (2)
evaluate user acceptance of the RISE system and the caregivers' attitudes toward it, and (3) assess the
accuracy and quality of the RISE system's interactions with caregivers. A pilot study is proposed to meet these
objectives, involving 30 caregivers at the O'Connor Senior Center in Knoxville, an institution with a diverse
visitor demographic. Participants will engage in full RISE sessions, interacting with the robot. Based on their
needs and preferences, participants will select knowledge modules, consisting of a presentation, question and
answer session, and knowledge quiz on behavioral topics such as bathing, wandering, or self-care and coping
topics such as asking for health, followed by their choice of stress management activity guided by the robot.
The sessions will then be evaluated using both quantitative and qualitative methods to assess user acceptance
and the system's accuracy. The findings from this pilot study will contribute valuable insights into the use of AI
and robotics in the caregiving context. This knowledge will inform the development of an optimized version of
the RISE system and will serve as a solid foundation for a larger, more comprehensive study in the future.

Public health relevance
Project Narrative This project leverages advanced artificial intelligence technology to support caregivers of persons with Alzheimer's disease and related dementias, by offering informative, interactive sessions with a social robot. Through engaging sessions, caregivers can gain vital knowledge, helpful strategies, and stress management techniques, which ultimately enhances their ability to provide care and improve their wellbeing. In the long term, our research aims to alleviate caregiver stress, promote healthier living conditions for both caregivers and persons with dementia, and improve the overall quality of dementia care.